Development and clinical evaluation of the CapScan gastrointestinal sampling device for metabolomics monitoring

Project Abstract
The goal of this project is to develop the CapScan gastrointestinal (GI) tract sampling capsule, and to utilize
this device to advance our understanding of gastrointestinal disorders. CapScan is a novel ingestible device
with the potential to routinely collect and analyze the microbiota of the GI tract, including the metabolic
transformation of food products by gut microbes. We will develop, bench test and assess the safety,
reproducibility, regional specificity of the CapScan device on healthy human volunteers. We will then utilize the
CapScan device in two additional studies to test the effect of a proton pump inhibitor (PPI) on the microbiome
and metabolome and to measure the regional differences in the GI tract in patients with small intestinal
bacterial overgrowth (SIBO) before and after antibiotic treatment. Given the centrality of the gut to human
health, there will likely be additional uses of the CapScan technology in monitoring a person's health,
eventually making CapScan as routine and informative in the practice of medicine as a blood test is today.

Public health relevance
Project Narrative Envivo Bio Inc. will develop the CapScan intestinal sampling capsule in order to generate a comprehensive and quantitative overview of metabolites and microbes in the human gut. Metabolite and gut bacteria analyses will be conducted in healthy volunteers and also in patients with common digestive problems to explore the extent of changes before and after treatment, ultimately setting the stage for CapScan to be used to study a broad range of gut disorders.